Development of a rapid, scalable, and deployable point-of-care blood volume diagnostic for monitoring postpartum and trauma-related hemorrhage

ABSTRACT
Postpartum hemorrhage (PPH) is the leading cause of maternal mortality globally, accounting for 1/4th of all
delivery-associated deaths. PPH is described as the cumulative blood loss of 1L or more with symptoms of
hypovolemia within 24 hours after giving birth. Recently, reports have demonstrated that about 53-93% of PPH-
related deaths could have been prevented by administering timely medical treatments and interventions.
Currently, OB-GYNs use subjective visual assessments of blood loss and patient condition or semi-objective
assessments of blood-soaked pads, drapes, and other materials that also absorb amniotic fluid, urine, and other
excretions along with blood at delivery. We can certainly do better: This represents a great unmet and critical
need given there is currently no quantitative method of assessing blood volume, or blood loss, to identify and
direct PPH treatment decisions and interventions. To address this need and in direct response to NOT-EB-
21-001, QuantiPort is developing a novel rapid, scalable, deployable, easy-to-use, and inexpensive point-
of-care BV diagnostic device to measure BV for postpartum and trauma-related hemorrhage in this NIH
SBIR Phase I application. To measure BV, our team has developed a unique approach comprised of a non-
imaging ultrasound transducer positioned on the skin, over a major blood vessel, which will quantify the
intravascular concentration of a microbubble (MB) tracer agent (Sonazoid®, GE Healthcare) injected
intravenously. The actual blood volume result can be obtained in under 3 minutes and assessments may be
repeated every 20 minutes to provide quantitative measurements over time to determine the rate of blood loss
or to assess the efficacy of therapeutic interventions. As the system design is simple and unwieldy, this small,
lightweight device can easily fit into existing clinical workflows. The proposed MB tracer is safe, non-radiolabeled,
has similar rheology to red blood cells to eliminate volumetric inaccuracies, and is stable at room temperature
for months to years. To execute the proposed studies, our objectives for this application include: 1) building a
manual non-imaging ultrasound system and optimizing the detection MB tracer agent using an in vitro vascular-
flow phantom, and 2) performing proof-of-concept testing of the BV diagnostic in vivo in Japanese macaques at
the Oregon National Primate Research Center. Successful execution of these studies will result in the
development of a unique and novel ultrasound system to accurately measure BV in a rapid, portable, and cost-
effective way for PPH and trauma care. Our goal is to ensure that QuantiPort’s device can effectively guide timely
and actionable interventions to improve maternal morbidity and mortality due to PPH, which is a key intention of
NOT-EB-21-001.

Public health relevance
PROJECT NARRATIVE There is currently a great unmet need for a novel quantitative method to measure blood volume in order to quickly identify and quantify significant postpartum hemorrhage (PPH) that results in approximately 25% of maternal deaths worldwide. To address this need, QuantiPort is proposing to develop novel and easy-to-use point-of-care diagnostic device that can safely, accurately, rapidly, repeatedly measure blood volume in labor and delivery patients without relying on traditional radiolabeled albumin techniques. Successful completion of our studies will result in a one-of-a-kind scalable and deployable blood volume measuring device that has the potential to alter the standard of care by reducing morbidity and mortality from PPH.